Retinal Ganglion Cell Replacement in Optic Neuropathies

PROJESCUTMMARY
Glaucioasmlaeadcianugsoefbslindanneadslsownigtohthoeprtniecuropaitcshiaersactbeyrize
thleososfretgiannagllcieol(nlRsGCIsn)c.reiansterdaporceuslsa(urIrOmePa)nagemietsnhcteurrent
standoafcradrfeogrlaucpoamtaiebnuftasit,losstotphierrevelrossoisfRbGlCeasnpdrogrevsissiuvael
dysfunVcitsiirooenns.totrhartoiRuoGgnChreplactehmeernoatnpoeyft,hNeElA'usdacGioauplsrsogram,
coubledapotenstoilaultaincodonn,sidperoagbrlheasbsseemnadienundersttahnmedoilnegcular
signtahlrasetguRlGaCtsepeciffircoahmtuimoasntecmelalswse,lalsinRGCtransapnlidannttegirnatio
rodeHnotwse.vwehre,cnonsidterrainnsgolflaatbiornaadtvoarnytcoheusmatnestriondgem,notdealrse
limibtycerditdiicffaelreinnrceetspihnyaslioalnopdgryo,of-ofi-ncoonn-cheupmrtainmawtoeugslrdeatly
increcaosnefidaennadciiedntherapdeeuvteilcopbmeefnomtroevitnohgumatnestTihnutgsh.eirsae
considneereafdboalrteractnaobnl-ehupmrainmmaotdeeHle.rweewielsltabalsiqsuhimrornekley-indu
glaucmoomdaealntdhpearamettosetrushduymasntecmell-dReGrCiinvteedgarnapdtoitoennvtiisailon
restorianrteitoainnnvdaissuyasltcelmotsoetrhoosfheumaTnh.routgh5hi-syeparropowsewailll
achicervietmiiclaelstionncelsuv,dailnigdtahtmeionngkgelyaucmoomdaeslt,udkyeisyntgrucatnudral
functmieoansaulurseisinngnovnaetwivmeodtahlsaihttoiueblsepdortbaebtlweemeonkaenyhdumans,
andemonsttrhametoidnegalb'istlomiotvyaecroisnsstitAulotlftihowinissbl.elaccompliintshhseeedtting
ofstudyRiGCntgransdpilffaenrte:nmtiigartailtooincio,anlt,egarnasdtyinoanfposremagtrioowdnto,hwtnhe
optniecrvaen,tdargettodiinsbgtraalniunclweiit,hgotaohlfveisrieosntoration.

Public health relevance
PROJECT NARRATIVE Glaucoma is a leading causes of blindness. Here we will establish a squirrel monkey-induced glaucoma model to study human stem cell-derived RGC cell transplant and integration and potential vision restoration in a retina and visual system closer to those of human. Through validating the monkey glaucoma model and studying key structural and functional measures using innovative new modalities that should be portable between monkey and humans, we will take significant steps towards the goal of vision restoration.